Functional role of RNA structure and m6A modification in viral genomes

PROJECT SUMMARY/ ABSTRACT
RNA viruses encode the information required to usurp cellular metabolism and gene regulation and to enable
their own replication in two ways: in the linear sequence of their RNA genomes and in complex higher order
structures. Although structured RNA elements are pervasive throughout viral genomes and have complex
regulatory effects on all stages of the virus life cycle, little is known about the extent to which RNA structures
occur across viral genomes or how critical structures function mechanistically. Post-transcriptional RNA genome
chemical modifications such as N6-methyladenosine (m6A) are regulators of infection in diverse viruses and can
have profound impacts on, or be impacted by, RNA structure. However, the link between RNA structure- and
m6A-mediated regulation of viral infectivity remains uncharacterized because we lack a comprehensive structural
understanding of RNA genomes and studies mapping m6A modifications have been imprecise. During the
mentored phase of this proposal, I will gain new training in virology, RNA epigenetics, and RNA chemical biology
to define how RNA elements and m6A modifications regulate viral replication and infection. In Aim 1, I will
characterize RNA structure interrelationships with the m6A post-transcriptional RNA chemical modification by
creating high-resolution RNA structure models and m6A modification site maps for the dengue virus (DENV) and
the respiratory enterovirus EV-D68 RNA genomes. No broadly effective vaccines or therapeutics are available
to prevent or treat the serious infections caused by these two single-stranded, positive-sense RNA viruses from
distinct virus families. Through Aim 2, I will establish the functional importance of m6A-related RNA genome
structures in DENV and EV-D68 viral life cycle stages using cell culture-based virus functional assays. Finally,
in Aim 3, I will define structure-function relationships in m6A-related RNA structures in DENV and EV-D68
genomes by evaluating dynamic changes in RNA structure, m6A modification, and protein binding. Together,
these studies will reveal the complex roles that interrelationships between RNA structure and m6A modification
play in regulating the life cycles of diverse RNA viruses and will identify novel RNA regulatory motifs that might
be exploited in the design of anti-DENV and anti-EV-D68 therapeutics and vaccination strategies. I have
assembled an expert team of mentors and collaborators and plan to attend workshops, seminars, and
conferences that will result in the training necessary to achieve the research goals proposed here and to
transition into a successful career as an independent research scientist. The excellent training environments in
the Weeks and Horner laboratories, along with hands-on training from my collaborator Dr. Cameron, will provide
me with a solid foundation on which to build a successful independent research program.

Public health relevance
PROJECT NARRATIVE RNA viruses account for many serious ongoing and emerging threats to human health, and are a critical challenge for global disease control. The proposed study will define how structured elements in RNA viral genomes, in coordination with the N6-methyladenosine post-transcriptional modification, regulate viral replication and infectivity. The proposed studies of dengue virus and respiratory enterovirus EV-D68, two single- stranded, positive-sense RNA viruses from distinct virus families, will reveal novel RNA regulatory motifs that might be exploited in the design of anti-DENV and anti-EV-D68 therapeutics and vaccination strategies.